Human Tissue Resource Center

PROJECT SUMMARY/ABSTRACT - HUMAN TISSUE RESOURCE CENTER (HTRC)
The University of Chicago Medicine Comprehensive Cancer Center (UCCCC) aims to improve the
prevention, detection, and treatment of cancer through our basic, clinical, translational, and population
research activities. The effective procurement, storage, distribution, and analysis of human biospecimens
are central to this research, and the maintenance and expansion of these state-of-the-art facilities is vital to
the future success of our cancer programs. Established in 2001, the Human Tissue Resource Center (HTRC)
supports the effective procurement, storage, use, and analysis of human biospecimens for University of
Chicago Medicine Comprehensive Cancer Center (UCCCC) investigators. The HTRC is a College of
American Pathologists (CAP)-accredited biorepository. The facility occupies ~4,000 square feet of renovated
space and functions as an integrated unit. The HTRC is comprised of four integrated Subcores: the
Biospecimen Bank, Laser Capture Microdissection, Digital Pathology, and Histology Services Subcores. The
HTRC provides services for the collection of clinically annotated human tissues, as well as blood, serum,
plasma, saliva, urine, stool and peripheral blood mononuclear cells for cancer research. In addition, HTRC
provides collaborative services for histopathology, immunohistochemistry and in situ hybridization, laser
capture microdissection (LCM), tissue microarray preparation (TMA), quantitative image analysis, and
nucleic acid extraction. In this way, we provide a coordinated, centralized, and dedicated program for
procuring, processing, dispersing, and assessing biospecimens. In the reporting period, HTRC supported
125 unique UCCCC members (29% MMC, 12% CPC, 16% IC, 42% CET), supporting their scientific needs
and meeting the strategic objectives of UCCCC. During this cycle, HTRC also supported 176 cancer-relevant
federal grants, and 201 cancer-relevant peer reviewed publications (53% in journals with impact factor ≥
10).
In summary, the HTRC is dedicated to our mission of procuring, processing, storing, distributing and
analyzing human cancer biospecimens in a manner that will improve the prevention, detection, and treatment
of cancer through UCCCC’s basic, clinical, translational, and population research activities. We will pursue
forward-thinking strategies to facilitate ongoing and future cancer research and provide cutting edge services
that will accelerate scientific progress.